PANCREATIC POLYPEPTIDE SECRETION IN ABNORMAL APPETITE AND WEIGHT

This study is designed to further explore the refractoriness of pancreatic polypeptide (PP) release in children with Prader-Willi syndrome; and to determine the PP response patterns in obese but otherwise normal children and compare these responses to those obtained in children with PWS and to normal children. The study will also investigate PP release in patients identified as having other clinical forms of altered appetite and weight such as ano- rexia nervosa and bulimia, and steroid-induced hyperphagia and obesity.